Traumatic Brain Injury Across the Lifespan in Zambia

Project Summary/Abstract
The overall goal of the Traumatic Brain Injury Across the Lifespan in Zambia (TBI-Zambia) program is
to define the health and economic burden of traumatic brain injuries across the lifespan in Zambia. We will do
this by strengthening the local data infrastructure with an electronic registry on traumatic brain injuries (Brain
Injury Registry of Lusaka (BraiL)) to collect data on all TBI seen at the University Teaching Hospital. Our
approach will involve close collaboration between Milken Institute School of Public Health, the George
Washington University (GW), USA, the University of Zambia School of Public Health (UNZA) and its University
Teaching Hospital (UTH), Lusaka, Zambia. GW and UNZA share a documented commitment to research
training, expertise in application of electronic registries in injuries and health services research, as well as a
history of productive collaborative work. UNZA and UTH share a commitment to providing the highest quality
service to the under-privileged communities in Zambia, and focus on optimizing outcomes in low-resource
settings. Our proposal will leverage the shared interest in understanding the impact of trauma and brain
disorders and strengthening research capacity and tackle two critical gaps in addressing these health concerns
– create national, disaggregated data on TBI, define their risks and vulnerable groups and the impact of
potential interventions and develop a core group of clinicians with research and data management skills. Our
TBI-Zambia collaboration will help strengthen capacity within UNZA/UTH and Zambia to apply these
methodologies to other areas of health care. The specific aims of this proposal are: (1) To Define core
variables and digital platforms for a data registry focused on traumatic brain injuries in Zambia; (2) To Pilot-test
a digital traumatic brain injury registry at University Teaching Hospital, University of Zambia for a year; and (3)
To Develop a core group of clinicians with research skills and data analysis capacity at University Teaching
Hospital, University of Zambia. We will apply the results of the study to reduce the growing burden of TBI
across the lifespan and propose a larger intervention study by the end of two years.
With TBI patients as our focus, we will develop digital registry, which will be implemented in the Surgical
Emergency Unit (where all trauma patients are received, assessed and treatment is initiated) of UTH.
Information on the epidemiology of the brain injury, occurrence, nature, type and outcomes of TBI including risk
factor analysis and seasonal variation will be collected through 12-month prospective data collection process.
The data will be crucial for evaluating future interventions and outlining policy recommendations. To strengthen
the response to TBI, we will develop research capacity among clinicians (surgeons, trauma surgeons,
neurosurgeons) in Zambia through hand-on onsite training, short-term workshops and online courses.

Public health relevance
Narrative The overall goal of the Traumatic Brain Injury Across the Lifespan in Zambia (TBI-Zambia) program is to define the health and economic burden of traumatic brain injuries across the lifespan in Zambia. We will do this by strengthening the local data infrastructure with the development of an electronic TBI registry to define epidemiology and outcomes of TBI in Zambia. We will develop a core group of clinicians with research skills and data analysis capacity at the University of Zambia Teaching Hospital in Lusaka.